The Effect of Screening and Referral for Social Determinants of Health on Veterans' Outcomes

Background: Despite medical advances, up to 70% of health outcomes are due to social determinants of
health (SDoH) - the conditions in which people live and work that shape whether basic needs (e.g., housing,
food) are met. These associations are especially well documented for cardiovascular disease (CVD). In
response, health policy leaders recommend screening and referral (S&R) for unmet needs in clinical settings,
and the American Heart Association recently concluded that the most significant opportunities for reducing
CVD death and disability lie with addressing the social determinants of cardiovascular outcomes. A limited but
promising evidence base supports these recommendations but more rigorous research is needed to guide how
best to intervene on unmet needs that affect health.
Significance/Impact: This project addresses the Office of Social Work’s priority to link Veterans with resources
and services in support of treatment goals, the Office of Patient Centered Care and Cultural Transformation’s
priority to enhance the physical, emotional, and social well-being of the whole person, the Office of Health
Equity’s priority to reduce disparities, and the HSR&D priorities of health equity and population health. Our
study will provide much-needed evidence to document the burden of Veterans’ unmet needs, inform how best
to address unmet needs, and assess how such a process can affect adherence (to medications and
appointments), utilization, and clinical outcomes.
Innovation: VA currently systematically screens for only two unmet needs (homelessness and food insecurity).
Identification of other unmet needs (and referral to address them) occurs on an ad hoc basis, with varying
approaches among clinics/ clinicians. We will implement comprehensive screening of eight unmet needs and
systematic referral, developing tools and processes that, if efficacious, can be implemented within VA (and
other) clinical systems. VA is currently funding several studies related to SDoH, but none test interventions that
systematically identify a wide range of unmet social needs among Veterans and connect Veterans with
identified needs to social service resources.
Specific Aims: 1) Describe the burden and distribution of eight unmet needs (i.e., housing; food insecurity;
utility insecurity; transportation; legal guidance; employment; safety; and social isolation) among Veterans with
or at-risk for CVD, and identify their associations with sociodemographic characteristics, and baseline health-
related behaviors and clinical outcomes; 2) Compare the effects of three S&R study intervention conditions of
varying intensity on Veterans’ connection to new SDoH resources (primary outcome), reduction of unmet
needs, adherence, and clinical outcomes, and 3) Identify barriers and facilitators to Veterans’ connecting with
social services and having needs met, and explanatory factors for observed RCT outcomes.
Methodology: We propose a 3-year, two-phased mixed methods study. In Phase One (Aims 1 and 2), we will
implement a three-armed randomized controlled trial at three VA sites to compare outcomes among Veterans
randomized within each site to one of three study conditions: screening only; screening plus provision of
tailored resource sheets; or screening plus resource sheets plus social work support. For each Veteran, we will
examine associations of unmet needs with baseline outcomes (Aim 1), and longitudinally examine the impact
of each approach on connection to new SDoH resources and follow-up outcomes over a 12-month period (Aim
2). In Phase Two (Aim 3), we will conduct interviews with Veterans and representatives of the VA- and
community-based programs to which Veterans are referred because of the trial to identify facilitators and
barriers and potential explanatory factors related to the relative success of the interventions.
Implementation/Next Steps: If the intervention yields positive results, findings will be used by partners to
support more widespread implementation of it throughout VA.

Public health relevance
The impacts of unmet social needs, such as homelessness, inconsistent access to food, and exposure to violence on health are well-established, especially for cardiovascular disease. A limited but growing body of evidence suggests that screening for and addressing these needs – also referred as social determinants of health -- in clinic settings helps to connect patients to resources to address unmet needs and has the potential to improve health outcomes. Veterans carry a high burden of unmet needs. At present, VA systematically screens for only two unmet needs; homelessness and food insecurity. We propose to assess the efficacy of systematically screening Veterans for eight unmet needs (i.e., housing, food insecurity, utility insecurity, transportation, legal problems, employment, safety, and social isolation), and compare the effect of referral mechanisms of varying intensity on Veterans’ connection to resources, reduction of unmet needs, treatment adherence, reduced preventable hospitalizations, and clinical outcomes.